FY23. Helping to End Addiction Long-term Initiative EOC Consultant.

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

The purpose of this requirement is to procure biological therapeutics consulting services in support of NIH Helping End Addiction Long-term (HEAL) drug discovery and development programs and the associated HEAL External Oversight Committee. The NIH is seeking to procure a highly experienced executive-level, drug discovery and development subject matter expert with experience in the area of pain therapeutics to provide feedback to the NIH program leadership and technical guidance on drug discovery and development projects within the HEAL portfolio. The Contractor will serve as a member of the HEAL External Oversight Committee, which provides strategic guidance on HEAL projects and on occasion other NIH drug discovery and development programs.

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.